FASD Inhibition of ASPH-Notch Mediates Adolescent Cerebral White Matter Pathology-Potential Utility of Non-invasive Extracellular Vesicle Assays

Long-term effects of fetal alcohol spectrum disorder (FASD) on the CNS vary with exposure dose, duration, and
timing. Despite decades of research, we still lack efficient means of detecting and therapeutically targeting the
damage. However, progress may have been limited by our failure to attend to the full spectrum of brain pathology
linked to neurobehavioral dysfunction. For example, besides neurons, alcohol exposures across the lifespan, but
especially during development, exert toxic/metabolic effects that impact the integrity of white matter (WM) myelin,
axons, and oligodendrocytes (OLs), yet the mechanisms are poorly understood. Dysfunction or loss of OLs
compromises the structure and function of myelin, impairing axonal conductivity. Preliminary studies showed that
developmental exposures to ethanol reduce the expression of mature myelin-associated genes and proteins, in
part due to impaired maturation of oligoprogenitor cells and/or survival of mature OLs. Attendant hypomyelination
and dysmyelination render WM axons vulnerable to toxic/metabolic injury and degeneration with loss of synaptic
connections. This competing renewal R37 application builds on our previous gains that mechanistically linked
ethanol-impaired insulin and IGF-1 signaling through PI3K-Akt and downstream pathways to deficits in neuronal
survival and migration during development. Another critical success of those experiments was that they revealed
how ethanol inhibition of aspartyl-asparaginyl-β-hydroxylase (ASPH) and Notch impair survival, maturation and
migration of immature CNS neurons. However, empirical observations and subsequent preliminary studies led to
the hypothesis that WM OLs may be similarly impaired by ethanol via disruption of Akt-mTOR-mTORC1/2 which
alters the composition and integrity of WM myelin. We now propose to extend these gains by determining how
ethanol inhibits insulin/IGF-Akt-mTOR-mTORC1/2 signaling and reduces ASPH-Notch activation in relation to
WM structure and function during postnatal and adolescent development. Aim 1 will delineate mechanisms of
long term FASD WM and OL pathologies by examining developmental stage-associated impairments in signaling
through insulin/IGF-1-PI3K-Akt-mTOR-mTORC1/2, and ASPH-Notch activation. Aim 2 will assess FASD dose-
dependent inhibition of sulfatide (ST) in relation to impairments in OL maturation; in many CNS diseases, ST
depletion in WM mediates cognitive-motor deficits. Aim 3 stems from preliminary studies showing that ethanol’s
effects on WM sphingolipid profiles, including STs, are detectable in peripheral blood circulating extracellular
vesicles (EVs). Therefore, we propose to examine the utility of MALDI Mass Spectrometry (MS) EV assays for
non-invasive detection of WM pathology and responses to treatments that restore ASPH-Notch pathways needed
for OL/WM maturation and function. Our hypotheses will be addressed with in vivo, slice culture, and isolated OL
models, quantitative immunohistochemistry, electron microscopy, multiplex ELISAs, mRNA analyses, and
MALDI-MS. The research is novel, mechanistic, robust, transparent, and inclusive of dose effects and both sexes.
The prospects for extending this research to humans via non-invasive MALDI EV assays are extremely high.

Public health relevance
This R37 competing renewal application is to use an established experimental model of fetal alcohol spectrum disorder (FASD) to characterize the mechanisms of long-term brain white matter (WM) pathology. Using multi- pronged innovative approaches, the proposed research will evaluate impairments in WM insulin/IGF signaling that are critical to survival, maturation, and function of oligodendrocytes (OLs); OLs generate and maintain myelin, enabling efficient neuronal conductivity for cognitive-motor functions. The research plan includes analysis of circulating extracellular vesicles that likely reflect FASD brain WM pathology and responses to treatment and have prospects for clinical application via high throughput non-invasive diagnostics and therapeutic monitoring.